Alterations and Renovations

The Northern New England Clinical and Translational Research Network (NNE-CTR) is comprised of the
MaineHealth Maine Medical Center Research Institute (MMCRI), the University of Vermont (UVM) and the
University of Southern Maine (USM). These institutions have a strong track record of translational research
and innovation in healthcare. Critical to the success of translational research is the availability of preclinical
animal models to identify disease mechanisms, and test drugs or other therapeutic approaches before moving
into the clinic. MMCRI has a strong mouse genome modification resource that has developed mouse models of
disease for over 15 years, and has been at the forefront of mouse genome modification using CRISPR-Cas
technologies. This resource is supported by an American Association for Accreditation of Laboratory Animal
Care accredited, state-of-the-art animal facility that houses mice and rats. The NNE-CTR supports, in part, the
Mouse Genome Modification Resource at MMCRI, which is accessible to all NNE-CTR members, as well as
non-members, COBRE supported investigators, and regional investigators. The high demand for the
generation of sophisticated mouse models of human disease by NNE-CTR members and other regional
translational researchers, combined with new faculty recruitment at MMCRI and increased use of animal
models by current faculty, has resulted in the need to expand animal housing space in our barrier animal
facility at MMCRI. The proposed renovation will convert a storage room into an additional mouse housing
room, and convert space adjacent to the animal facility into a storage area. The renovation to create a new
mouse housing room will require extensive changes to the HVAC system, and moving doors to bring the new
animal room inside the barrier portion of the animal facility. The expansion will accommodate housing of new
mouse models developed for NNE-CTR members, as well as other translational investigators in the region. By
expanding mouse housing facilities, both the generation of new mouse models and the experimental protocols
to investigate these new mouse models will be advanced more rapidly and cost-effectively.